Investigating Endocytic Mechanisms in Lysosome Rich Enterocytes

ABSTRACT
Nutrient absorption in the neonatal mammalian gut relies on intracellular digestion by a population of enterocytes
known as vacuolated or neonatal enterocytes. Recently, we showed these cells are conserved between
zebrafish and mammals and are specialized in the uptake and digestion of dietary proteins. As these cells
possess a prominent lysosomal vacuole and are present in non-mammalian vertebrates such as fish, we refer
to them as Lysosome Rich Enterocytes (LREs). In our previous studies, we found that protein uptake in zebrafish
and mouse LREs is mediated by a scavenger receptor complex composed of cubilin (Cubn), its transmembrane
partner amnionless (Amn), and the endocytic adaptor Dab2. However, the cellular mechanisms that allow LREs
to internalize cargo from the intestinal lumen at an astounding rate are unknown. Here, we will leverage the
experimental advantages of the zebrafish system and the conserved biology of LREs to investigate the endocytic
machinery that allows these cells to support dietary protein absorption in the intestine. Specifically, we will
elucidate the mechanisms regulating a specialized form of clathrin mediated endocytosis that confers LREs a
high capacity for luminal protein uptake.

Public health relevance
PUBLIC HEALTH RELEVANCE The proposed studies will investigate mechanisms regulating endocytosis in Lysosome Rich Enterocytes (LREs) in zebrafish. These studies will provide valuable insights into the mechanisms controlling protein absorption in the vertebrate gut. Because LREs and their physiology are conserved between zebrafish and mammals our studies are relevant for human intestinal physiology, particularly infant nutrition and development.